Functions of BRCA1 and RAD51 Paralogs in Genome Stability and Tumor Suppression via Homologous Recombination

Project Summary/Abstract
The broad objective of this proposal is to understand the molecular mechanism of homologous
recombination in humans, and to understand how the consequences of defects in recombinational DNA repair
result in chromosomal instability and predisposition to cancers. Understanding the functions of key proteins in
homologous recombination, many of which are tumor suppressors, will provide insight into how mutations in
these proteins can predispose individuals to cancer. We plan to elucidate the biochemical roles and examine
the mechanism of BRCA1, BLM, EXO1, PALB2, WRN, and the RAD51 paralogs (RAD51B, RAD51C,
RAD51D, XRCC2, and XRCC3) functions, as well as the consequences of the interactions between these
proteins, to provide insight into their role in recombinational DNA repair. We plan to reconstitute the initial steps
of human recombinational DNA repair, focusing on the DNA resection step, and thereby understand the
biochemical functions of these proteins. In addition, we will use single-molecule technologies to reveal the
molecular mechanisms by which these proteins act.

Public health relevance
Project Narrative It is now abundantly clear that mutations in many of the key proteins involved in human recombinational DNA repair result in chromosomal instability which, in turn, translates into a predisposition for cancers. The results from these studies will provide unique molecular insights into the macromolecular assemblies that are crucial for genetic stability and tumour suppression. Understanding the function of these proteins, and the failings of proteins defective in this process is consequently of importance to human health.